Role of the gut microbiota and cell-mediated immunity in vaccine-induced mucosal immunity to Polio Virus

PROJECT SUMMARY: Jessica Crothers, MD, Research Project Leader (RPL)
Paralytic Polio is a devastating cause of flaccid paralysis, and its eradication is a major initiative of the World
Health Organization (WHO). Critical to eradication efforts is control of viral shedding and environmental
transmission of poliovirus (PV). While live attenuated oral poliovirus vaccines (OPV) have been widely effective
in establishing sterilizing mucosal immunity and limiting human to human transmission, viral strains used can
revert to neurovirulence while being shed in the feces of vaccinees such that its use perpetuates the existence
of an environmental reservoir of disease. Alternatively, inactivated polio vaccines (IPV) do little to establish
mucosal immunity and limit viral shedding despite their ability to generate protective antibody responses. If
polio eradication efforts are to be realized, new PV vaccine strategies and enhanced understanding of the
immunologic mechanisms responsible for effective mucosal immunity to PV are critically needed. Dr. Crothers
will maximize evaluation of existing data and biospecimens from key clinical PV vaccine-challenge studies to
characterize the immunologic target profile of PV mucosal immunity and investigate whether leveraging
immune-microbiota interactions, including through use of a novel mucosal vaccine adjuvant, offer a path
forward in the fight to eradicate polio.
In addition to protective immunity to prevent disease, mucosal immunity is an important vaccination goal to limit
pathogen transmission. This project will seek to comprehensively characterize the immune responses of
human subjects during PV challenge and compare those of individuals with and without effective mucosal
immunity to identify immunologic target profiles associated with effective mucosal immunity to PV. The
immunologic impact of a novel mucosal adjuvant (dmLT) combined with IPV will be evaluated to assess its
ability to stimulate target immune profiles. Lastly, the impact of the gut microbiota on PV replication and
transmission dynamics will be investigated during PV challenge. Altogether, this work will provide a critical step
in understanding the role of adjuvants and the gut microbiome in the development of mucosal immunity to PV.
This work aligns with the NIAID 2018 strategic plan on vaccine adjuvants which highlights development of
mucosal adjuvants with an emphasis on maximizing evaluation of clinical trial data to enhance understanding
of their mode of action.